Alaska INBRE 4 One Health

OVERALL PROJECT SUMMARY
Alaska INBRE enhances capacity to conduct biomedical and behavioral health training and research within its
network of the three universities of the University of Alaska system, the tribally-led Iḷisaġvik College,
Southcentral Foundation, and Alaska Native Tribal Health Consortium. AK INBRE continues with its One
Health research theme that emphasizes the importance of recognizing the interconnections among the health
of people, communities, animals, and their shared environment in the rapidly changing state of Alaska. The AK
INBRE Administrative Core coordinates and leads the network-wide annual research conference, proposal and
career development workshops, and offers research administration advice to other NIH capacity building
programs in Alaska. The Management Advisory Committee of network representatives contributes to AK
INBRE management decisions for the network. The Steering Committee of senior leadership from the network
institutions offers advice and counsel to the AK INBRE leadership on program foci, effectiveness, and impact
including responses to program challenges. The Developmental Research Project Program awards for Pilot
and Research Projects prioritize applications by investigators emphasizing One Health, as positively peer-
reviewed by external experts and recommended by a national External Advisory Committee. The Research
Experiences Core supports a student research program with research internships and career development
opportunities for undergraduate and graduate students in addition to training opportunities in data science,
analytic chemistry, genomics, biomarker development, and community based participatory research (CBPR),
towards preparing a growing pipeline of students in Alaska entering into biomedical research careers.
Research support in the Bioinformatics Core promotes data science, the research analytics for genomic,
chemical, and stable isotope analytics, and the CBPR for community engaged research for investigators
throughout the AK INBRE network in their development towards sustainable independent grant support as well
as engaging students at their home institutions. The Sustaining Research Excellence Core is especially
important for CBPR in the engagement of communities and local leadership together with investigators in the
selection and approach of research questions and the dissemination of results. The INBRE program has been
and will remain crucial to the success of students, faculty, and investigators in the ecosystem of biomedical and
health research in Alaska.

Public health relevance
OVERALL NARRATIVE The Alaska Institutional Development Award (IDeA) IDeA Networks of Biomedical Research Excellence (INBRE) program invests in growing and enhancing the capacity of biomedical and behavioral health researchers to improve the health and well-being of Alaska and the nation. It also supports increasing and diversifying the pipeline of students seeking careers in biomedical research in Alaska. Through its One Health research theme and focus on health disparities in Alaska Native people, it emphasizes the importance of recognizing interconnections among the health of people, animals, and the environment to sustain healthy communities during a time of rapid change in the northern-most state.